Duration of Immunity Elicited by Pertussis Vaccines

The overall goal of the study is to use a model that mimics pertussis infections in humans to study duration of the immunity elicited by aP and wP (whole cell killed pertussis) vaccines.